Neuroprotection by a Secreted Component of the Cellular Stress Response

PROJECT SUMMARY
We propose that the secreted luminal domain of the ER membrane-bound transcription factor CREB3L2,
TAILS, is a signal for the transmission of adaptive cell stress response in neurons. Previously, we discovered
that CNS neurons exposed to variety of degenerative stimuli, including oxidative stress, secrete TAILS.
Application of TAILS in a low nanomolar concentration to primary neurons improved survival under oxidative
stress. TAILS acts by increasing SHH signaling and increasing the mitochondrial fitness and redox capacity in
stressed neurons. In our preliminary experiments, we found that TAILS boosts neuronal resilience not only
against oxidative insults but also against stress triggered by the application of the Alzheimer's disease
peptide oligomeric Aβ1-42. In this proposal, we are testing our general hypothesis that activation of the
integrated stress response in neurons in AD brain triggers the production and secretion of TAILS, which acts
as a paracrine signal enhancing SHH signaling thereby boosting resilience to Aβ1-42-induced neuronal stress.
The successful completion of this research project will uncover a novel non-cell autonomous branch of
adaptive stress signaling that is activated in neurons in response neurodegenerative stress and confers
enhanced resilience and mitochondrial function to receiving cells. The expected results from this project will
establish TAILS as a stress-regulated modulator of protective neuronal SHH signaling in AD, and it will provide
evidence for intercellular communication of the ISR in the mammalian nervous system with implications for
neurodegenerative conditions. Moreover, this project will lay the groundwork for two major new directions: (1)
the requirement of cell stress for the secretion of TAILS suggests that it might be useful as a biomarker for
early degenerative conditions in the brain; and (2) TAILS (or peptides derived from it) are potential compounds
for boosting neuronal resilience in the context of AD and other degenerative conditions.

Public health relevance
PROJECT NARRATIVE The integrative stress response is an evolutionary conserved pathway to allows cells to react to various stress stimuli to restore cellular homeostasis. We found that the activation of this process in neurons leads to the secretion of a protein fragment that enhances the resilience of surrounding cells to cell stress. We propose to study how this signaling molecule is generated and secreted from neurons in response to stress, how it affects recipient neurons, and how its activity is coordinated with transcriptional programs to facilitate cell survival.